Informing Lifestyle Recommendations for Kidney Cancer Survival: Investigating the Role of Dietary Patterns and Physical (In)activity

PROJECT SUMMARY
Renal cell carcinoma (RCC) accounts for 4.1% of new cancer cases in the United States (US) – 1 out of
every 25 diagnoses – and the number of individuals living with the disease has consistently increased over the
past five decades. When patients are diagnosed with RCC, they often ask: “What can I do to improve my
chance of survival?” A cancer diagnosis is a “teachable moment,” a time when an individual may be open to
behavior change. But what behaviors should be endorsed? As yet, sufficient data are unavailable to give
evidence-based, disease-specific lifestyle recommendations. Few studies have considered modifiable
behaviors that might improve survival. Such studies are imperative given that 14,000 individuals die from RCC
in the US each year. As such, we seek to comprehensively study the associations of dietary patterns and
physical activity with RCC survival using data from three large, prospective cohorts: the Health Professionals
Follow-up Study, Nurses’ Health Study, and Nurses’ Health Study 2. These cohorts are unique in their
collection of repeated food frequency questionnaires (FFQs), physical activity assessments, and extensive
covariable data, both before and after diagnosis. They also include more than 1000 confirmed cases of RCC,
among whom roughly 300 have died from disease. In Aim 1, we will use FFQs to compute pre- and post-
diagnostic adherence to the alternative healthy eating index (AHEI) and Dietary Approaches to Stop
Hypertension (DASH), type 2 diabetes prevention, inflammatory, and insulinemic diets. We will then evaluate
RCC-specific and overall mortality among RCC patients in relation to adherence to each pattern post-diagnosis
and change in adherence to each pattern from pre- to post-diagnosis. Due to its impact on hypertension, we
hypothesize that adherence to the DASH diet will be most strongly protective against RCC-specific mortality,
even relative to an otherwise healthy diet (AHEI). In Aim 2, we will evaluate RCC-specific and overall survival
among RCC patients in relation to post-diagnostic physical activity (including by volume, type, and intensity),
post-diagnostic sedentary behavior, and pre- to post-diagnosis change in physical (in)activity levels. We
hypothesize that increasing physical activity will be associated with a reduced risk of RCC-specific mortality
and that increasing sedentary behavior will be associated with a greater risk of RCC-specific mortality. Results
will offer first ever insights into dietary choices that improve RCC survival, and results regarding physical
(in)activity will be borne from analyses including over five times the number of outcomes as had the prior
pertinent study. Our research will thus yield a foundation for developing evidence-based lifestyle
recommendations for RCC survivors. Only equipped with data from rigorous and well powered research can
we offer RCC patients some self-determined control over their outcomes.

Public health relevance
PROJECT NARRATIVE A cancer diagnosis is a “teachable moment” – a time when an individual may be open to behavior change – but few studies have considered modifiable lifestyle factors that might improve disease-specific survival in individuals diagnosed with renal cell carcinoma (RCC). We propose to comprehensively investigate the roles of dietary patterns and physical activity in RCC survival in three large, prospective cohorts with longitudinal food frequency questionnaires, physical activity assessments, and covariable data. Our findings will yield a foundation for developing evidence-based lifestyle recommendations for RCC survivors.